USP30 Inhibition as a Therapeutic Strategy in Parkinson's Disease

A large body of evidence implicates dysfunction of mitochondrial homeostasis as a key pathophysiological
mechanism in Parkinson’s disease (PD). Maintenance of a pool of healthy functioning mitochondria requires a
system for selectively degrading dysfunctional mitochondria (“mitophagy”). Autosomal recessive (AR) PD due
to Parkin deficiency links directly to a defect in mitophagy. Mitochondrial dysfunction causes Parkin to
translocate to the outer mitochondrial membrane where it interacts with PINK1 (another gene where mutations
cause AR PD) to ubiquitinate mitochondrial proteins, thereby inducing fusion of mitochondria with
autophagosomes, followed by autophagic degradation. Thus, loss of Parkin leads to the accumulation of
dysfunctional mitochondria due to impaired mitophagy. . In this context, we hypothesize that enhancing
mitophagy will protect against α-synuclein (αSyn) toxicity ΑSyn induces mitochondrial complex I dysfunction,
potentially by directly binding to TOM20 on the mitochondrial membrane and thereby interfering with
mitochondrial protein import. Conversely, dysfunctional mitochondria produce increased reactive oxygen
species (ROS), consistent with increased markers of oxidative damage in the PD brain. Furthermore, ROS can
increase αSyn accumulation. However, the role of mitophagy in clearing away dysfunctional mitochondria in
the setting of αSyn induced mitochondrial impairment is unknown. USP30 is a deubiquitinating enzyme (DUB)
tethered to the outer mitochondrial membrane, where it directly removes ubiquitin that had been attached by
Parkin, thereby counteracting Parkin’s ability to promote mitophagy. Knock-down of USP30 by siRNA rescues
mitophagy in Parkin-deficient cells and protects dopaminergic (DA) neurons in Parkin-deficient Drosophila. And
our preliminary data suggest that USP30 knock-out mice show enchanced mitophagy and protection against
αSyn toxicity. Thus, inhibition of USP30 is an attractive therapeutic strategy for restoring mitophagy to achieve
neuroprotection in PD. These data highlight the major potential for neuroprotection in PD by specifically
modulating mitophagy through targeting of USP30. With this goal in mind, we now propose to test a highly
specific CNS-penetrant small molecular inhibitor of USP30 for neuroprotection in a slowly degenerative αSyn-
based mouse model of PD, and to assess the degree to which αSyn clearance and neuroprotection relates to
the impact of USP30 inhibition on specific pathways mediating αSyn degradation. These results could provide
support for moving forward with MTX012 or other brain-penetrant pharmacological USP30 inhibitors towards
clinical neuroprotection studies in PD.

Public health relevance
Dysfunction of mitochondria (the energy producing parts of cells), contributes to Parkinson’s disease (PD), possibly in part by exacerbating the toxicity of α-synuclein, a protein that accumulates in vulnerable brain cells in PD and contributes to neurodegeneration. Maintaining healthy mitochondria requires degradation of dysfunctional mitochondria (mitophagy), but mitophagy may be impaired in PD. We now propose to test the neuroprotective efficacy in an α- synuclein based mouse model of PD of a small molecule that enhances mitophagy by inhibiting USP30, which itself normally inhibits mitophagy, thus potentially validating USP30 inhibition, and this small molecular in particular, as a therapeutic strategy in PD.